Oversight and Project Management Component

OVERSIGHT AND PROJECT MANAGEMENT COMPONENT ABSTRACT
Well-designed research is urgently needed to examine the impact of environmental exposures on health
outcomes in children. To address these knowledge gaps, the Environmental influences on Child Health
Outcomes (ECHO) program promises to leverage extant and new pediatric cohorts to test new hypotheses of
how environmental exposures impact pediatric health. The Duke Clinical Research Institute (DCRI) proposes
to serve as the ECHO Coordinating Center (ECHO CC) to provide the organizational framework for the
management, direction, and overall coordination of all common ECHO activities. DCRI is uniquely poised to
lead this ambitious initiative. As the world's largest academic research organization, DCRI manages >30 active
network and administrative coordinating center grants and has emerged as a leader in pediatric clinical
research. In order to facilitate innovative, rigorous study protocols tailored to the scientific hypotheses;
implement protocols across a network of pediatric cohorts; and provide study support to ensure high quality
study operations and timely completion, the DCRI will establish the ECHO CC Oversight and Project
Management Component. The specific aims of the Oversight and Project Management Component, led by
Drs. Brian Smith and Linda Adair, are to 1) oversee development and implementation of a standardized ECHO
Cohort Protocol 2) monitor progress of the ECHO Cohort and individual Cohort Study Sites; and 3) coordinate
diversity, equity, inclusion, and accessibility activities across the ECHO Program. The Oversight and Project
Management Component will include two teams: the Study Development and Implementation Team and the
Site Activation and Progress Team. The Study Development and Implementation Team will be responsible for
facilitating the refinement, review, and monitoring of the ECHO Cohort Protocol, specifically incorporating the
new preconception section and any subsequent protocol amendments. The Site Activation and Progress Team
will be responsible for ECHO Cohort Study Site partnerships; site management and monitoring; and central
IRB support.